STANDARDS FOR SURFACE ANALYSIS

Standard reference materials are of great usefulness, both for instrument calibration and for the interpretation of complex spectra. By understanding the spectra of each component making up a system, justifiable conclusions can often be drawn about the multicomponent system. The categories of standard substances under investigation are: self-assembled monolayers, poly(amino acids), proteins, "ordered" protein surfaces, polysaccharides, plasma-deposited surfaces, and conventional polymers. All reference materials must meet a number of criteria. They must be of high purity and possess a well-defined stoichiometry. They must also be stable upon storage as well as under low energy electron and X-ray flux. Finally, the information obtained should be generally useful in the interpretation of spectra originating from NESAC/BIO projects.